Nongenomic Coregulators of RXRalpha

PROJECT SUMMARY Retinoid X receptor-α (RXRα), a unique member of the nuclear receptor superfamily, acts as a ligand- dependent transcription factor by recruiting coregulators to positively or negatively regulate target gene transcription. RXRα also acts nongenomically in the cytoplasm to crosstalk with different signaling pathways. However, the mechanisms by which RXRα exerts its nongenomic activities remain obscure. We propose that the nongenomic action of RXRα is regulated by a set of cytoplasmic coregulators that act as counterparts to nuclear coregulators, and that the effect of the nongenomic coregulators can be modulated by ligands via a unique binding mechanism. This innovative hypothesis is built upon our published and preliminary results. We previously reported that RXRα is proteolytically cleaved in cancer cells, resulting in an N-terminally-truncated RXRα (tRXRα) protein that resides in the cytoplasm, where it activates phosphoinositide 3-kinase (PI3K) signaling by interacting with its p85α regulatory subunit. Recently, we discovered that an LxxLL motif utilized by genomic coactivators for binding to the coregulator-binding site (CoRBS) of nuclear receptors is present in p85α and required for binding. Our preliminary results also identified two tumor necrosis factor receptor (TNFR)-associated factors, TRAF2 and TRAF6, as potential nongenomic coregulators of tRXRα that regulate its activation of NF-κB. In our effort to identify and characterize small molecules for inhibiting tRXRα activities, we found via structural analysis that Sulindac-derived analogs bound to previously unrecognized sites on tRXRα to stabilize its tetrameric state, leading to dissociation of p85α. We also discovered a small molecule that binds to CoRBS of tRXRα and prevents its interaction with p85α. In this application, we propose a multidisciplinary approach to address our hypothesis, with 4 Aims: (1). Determine whether p85α, TRAF2 and TRAF6 serve as nongenomic coregulators of tRXRα. We will employ mutagenesis coupled with biological analysis to address the role of CoRBSs in tRXRα and cognate binding motifs in p85α, TRAF2, and TRAF6. (2). Define the structural and functional determinants of RXRα/peptide and protein complexes using complementary crystallographic and functional approaches. (3). Design and identify small molecules that regulate the interaction between tRXRα and its nongenomic coregulators. We will optimize compounds for stabilizing tRXRα tetramerization and for directly inhibiting coregulator binding. (4). Study the role of tRXRα and inhibitors in the development of the inflammatory tumor microenvironment using co-culture assays, and in the growth of tumor in nude and transgenic mice, which will also be used to evaluate inhibitors of nongenomic coregulators. Results obtained from this study should unravel fundamental regulatory mechanisms for the nongenomic action of RXRα (and perhaps other nuclear receptors), and may lead to the identification of new RXRα modulators for therapeutic intervention and mechanistic study.

Public health relevance
PROJECT NARRATIVE Aside from functioning as a ligand-dependent transcription factor, retinoid X receptor- (RXR) also acts nongenomically in the cytoplasm to crosstalk with different signaling pathways. This application proposes to test the hypothesis that the nongenomic action of tRXR is regulated by a set of cytoplasmic coregulators that act as counterparts to nuclear coregulators of RXR and that this type of regulation can be modulated by ligands that utilize unique binding mechanisms, which could in turn provide novel mechanistic probes and leads with translational potential.